Continuous measurement and control of intraocular pressure in normal and glaucomatous eyes

PROJECT SUMMARY
Regulation of intraocular pressure (IOP) is a subject of considerable scientific, clinical, and pharmaceutical
interest. High IOP is an established risk factor for glaucoma, an insidious disease that causes blindness by
killing retinal ganglion cells, so lowering IOP is a primary focus of all current treatments. The first approach
in clinical care is to prescribe patients medicines that alter the production and outflow of aqueous fluid in the
eye. Many of these medicines achieve a therapeutic effect by targeting signals from the autonomic nervous
system, which dynamically modulates aqueous humor dynamics for reasons that are not entirely known.
One of the strongest modulators is the suprachiasmatic nucleus in the brain, which coordinates a circadian
rhythm in mean IOP. Other autonomic neuromodulators include stress and intracranial pressure (ICP). Their
collective actions cause IOP to fluctuate continually, sometimes reaching levels that would cause glaucoma
in some individuals if maintained for extended periods. Involvement of ICP in IOP modulation is particularly
intriguing because ICP contributes to the translaminar pressure gradient across the optic nerve head, which
determines the mechanical stress and strain profiles experienced by retinal ganglion cell axons as they exit
the eye to the brain. ICP could therefore factor into glaucoma pathophysiology as well.
The proposed research is directed at advancing our understanding of circadian and autonomic mechanisms
of IOP modulation and the potential involvement of these mechanisms in disease onset and progression. To
do this, one-of-a-kind technologies are used that provide researchers the ability to record or control IOP or
ICP round-the-clock in rats. IOP, ICP, body temperature, locomotor activity, aqueous outflow facility, and
ocular compliance will be concurrently recorded in various combinations as ambient light-dark cycle is
altered, sympathetic nerve agonists and antagonists are administered, and variable pressure loads are
transiently applied to the eye. In so doing, new insights will be gained about the origin and control of ocular
rhythms, about efferent control of IOP by ICP, and about possible roles of circadian and autonomic systems
in glaucoma. These insights could lead to new approaches and targets for disease treatment.

Public health relevance
PROJECT NARRATIVE Glaucoma is an ocular disease that causes progressive and irreversible vision loss by damaging optic nerve fibers as they exit the eye. High eye pressure is a well-established risk factor for the disease, but it is not the only factor. This project uses one-of-a-kind technology that we have created for monitoring and controlling pressure in conscious animals to examine mechanisms and possible contribution of circadian fluctuations in eye pressure, eye pressure history, and brain pressure to glaucoma.